Molecular Basis for Membrane Lipid Homeostasis

Abstract
The lipid composition of the membrane bilayer surrounding different cellular organelles is unique both in terms
of structural lipids and signaling lipids like the phosphoinositides, lending each compartment distinct biochemical
and biophysical characteristics intrinsic to its function. In this MIRA proposal, we address the fundamental and
largely unexplored question of how cells maintain these distinct lipid compositions, even in light of continuous
vesicle trafficking and lipid exchange between compartments. Our research will focus on two poorly understood
mechanisms for controlling lipid homeostasis: lipid exchange at membrane contact sites and lipid remodeling by
multi-functional phosphoinositide kinase/phosphatase complexes. Membrane contact sites, where two
organelles come into close apposition, are emerging to play a critical role in membrane lipid dynamics and
homeostasis. To discover the processes occurring at such sites and their molecular basis, we are exploring
which proteins localize there, what their function is, how and when are they recruited there, and how their activity
is regulated. Our studies in the next project period will focus on VPS13 and related proteins, suggested by our
preliminary data to comprise a new family of lipid transport proteins. These studies promise exciting new insights
into membrane biology, including for the long-standing questions of how mitochondria and the autophagosomal
isolation membrane, neither connected to well-established vesicular trafficking pathways, may acquire their
membrane lipids. Membrane contact sites can also modulate the levels of phosphoinositide lipid species present
at different compartments, but regulation by lipid kinases and lipid phosphatases peripherally associated with
the membrane bilayer of individual organelles likely plays a more significant role in controlling local
phosphoinositide levels. To better understand the mechanisms governing phosphoinositide homeostasis, we are
characterizing these enzymes, which reversibly interconvert phosphoinositide species via the phosphorylation
and dephosphorylation of their inositol headgroups. In particular, in the next project period, we will focus on how
levels of phosphatidylinositol-(3,5)-bisphosphate (PI(3,5)P2), which plays a central role in the biology of the
lysosome/vacuole, are regulated by the PIKfyve complex. The mechanisms underlying PI(3,5)P2 metabolism
have been elusive, owing in part to the complexity of this assembly which comprises at least three different
proteins and antagonistic lipid kinase and lipid phosphatase activities. Studying this complex in vitro, separate
from the many processes ongoing in living cells, will be critical in understanding how PI(3,5)P2 synthesis and
degradation are individually regulated and ultimately coordinated. For these projects, we will leverage our
expertise in structural, biochemical, and biophysical techniques in vitro, then test arising hypotheses functionally
via well-established collaborations or in consultation with cell biologist colleagues.

Public health relevance
Project Narrative The lipid composition of the membrane bilayer surrounding different cellular organelles is unique, lending each compartment unique biochemical and biophysical characteristics intrinsic to its function and the physiology of the cell. Here we address the fundamental question how cells maintain these distinct membrane lipid compositions. Dysfunction in membrane lipid homeostasis is linked to a number of neurological disorders, including Alzheimer's and Parkinson's diseases, among many others. Our work will inform regarding disease mechanism, prerequisite for the development of therapeutic strategies.